Evaluating the associations of hearing loss with cognitive and brain health outcomes in midlife

Project Summary
Emerging evidence suggests hearing loss may be a modifiable risk factor for Alzheimer's disease (AD) and
related dementias (ADRD). Midlife (ages 45-65) could be a critical period when screening and intervention to
prevent AD/ADRD may be most effective. Indeed, increasing evidence suggests there are detectable changes
in midlife cognition and brain health associated with risk factors, such as vascular disease, which may presage
an increased risk for dementia in late life. Age-related hearing loss also often begins in midlife. As such, the
recent Lancet commission on dementia prevention highlighted hearing loss in midlife as a target for dementia
prevention. However, prior investigations have focused on hearing loss and cognition in older adults. There is a
critical gap of knowledge as to whether hearing loss is associated with cognition or markers of brain health in
middle-aged adults. There is also a critical gap in studies on hearing loss and cognition in underrepresented
populations, subgroups at higher risk for AD/ADRD, and the intersection with social determinants of health.
Addressing these gaps would inform intervention strategies targeting hearing loss, AD/ADRD risk, and health
inequities. We have an exciting and unique opportunity to study the relationship between hearing loss and
midlife cognition and brain health in the Coronary Artery Risk Development in Young Adults (CARDIA) study.
CARDIA is a biracial study of Black and White men and women with a spectrum of educational attainment with
measures of audiometric hearing loss, a standardized cognitive battery, and structural brain MRI from the most
recent exam, when participants had a mean age of 60. The goal of this study is to clarify the associations of
hearing loss with cognitive and brain aging in middle-aged adults. In Aim 1, we will test whether pure tone
audiometric hearing loss is associated with cognitive test scores, including methods to account for potential
cognitive testing error due to hearing loss. In Aim 2 we will examine the association of hearing loss with
cognition among subpopulations with differing background risk of AD/ADRD. Primary subgroups will be defined
by race, sex, and APOE genotype; we will also explore subgroups by education, income, and social isolation.
In Aim 3, we will investigate whether hearing loss is associated with brain volumes linked to higher AD/ADRD
risk (e.g., hippocampus and white matter hyperintensities). We propose a cost-efficient study that will link
newly collected objective hearing tests with cognitive and brain MRI assessments in a well-characterized and
diverse midlife cohort. Identifying associations between midlife hearing loss and cognition and brain MRI would
offer an important avenue for prevention and risk stratification. Importantly, this project will help lay the
groundwork for future studies evaluating the role of midlife risk factors for AD/ADRD and identifying
intervention targets to prevent cognitive decline.

Public health relevance
Project Narrative Hearing loss in midlife (ages 45-65) is posited as a target for preventing Alzheimer's disease and Alzheimer's disease related dementias, but it is unknown whether hearing loss is associated with cognition or brain health in midlife. This study will link newly collected objective hearing tests with cognitive and brain MRI assessments in a well-characterized and diverse cohort of middle-aged adults. This study's findings will provide critical insights into midlife haring loss and brain health, which may offer an avenue for reducing late-life dementia risk.